Epstein-Barr virus EBNA1 IgA as a biomarker in nasopharyngeal carcinoma risk prediction

ABSTRACT
Southeast Asian and immigrant Chinese communities across the globe have disproportionately high NPC
incidence, averaging 25-30 times higher than the general population in neighboring areas. EBV infection is
extremely common and more than 95% of adults have seroconverted, but only a subset of chronic carriers will
develop EBV-associated nasopharyngeal carcinoma (NPC). Latent and clonal EBV infection occurs in the tumor
cells, and a variant of a key EBV protein (EBNA1 Val487) required for co-infection with the host has been
identified as a cancer risk-variant because it is found in nearly all (98.8%) NPC tumors from NPC-endemic areas.
Both EBV serology and EBV DNA sequencing are informative. Early detection screening programs by one of
two screening methods (IgA serology, or next-gen sequencing of plasma cell-free EBV DNA) have been
recommended for NPC-endemic populations. However, the screening time-interval for routine early detection is
not known. A biomarker that can identify high-risk individuals several years before clinical onset would greatly
benefit from an early detection screening program.
Antibodies to EBV proteins rise several years before NPC onset. IgA serology is a sentinel for aberrant EBV
infection at mucosal sites. We previously surveyed EBV IgA/IgG/IgM serology from the serum of incident NPC
cases in a Singapore prospective cohort (discovery cohort) and tested the leading biomarker (EBNA1 IgA) in an
additional validation cohort from Shanghai, China. The sojourn time for the custom EBNA1 IgA assay was 4
years before NPC diagnosis (100% sensitivity, 100% specificity in 20 case-controls). False-positives emerged
in the expanded control samples which is likely attributed to periodic EBV reactivation but background signal
could be minimized by removing cross-reactive epitopes yielding a satisfactory EBNA1 IgA assay (93.7%
specificity at 100% sensitivity). Following on from the case-control study performed on a low-throughput but
highly accurate multiplex immunoblot assay, the goal of this proposal is to develop a high-throughput EBNA1
IgA assay using a prototypic slot blot assay and applying the principles from EBNA1 mapping studies. By
leveraging EBV serology, this work is expected to produce a high-throughput assay for NPC risk assessment.
Identified high-risk individuals would benefit from an NPC early detection screening program and/or clinical
follow-up.

Public health relevance
NARRATIVE Nasopharyngeal carcinoma (NPC) accounts for more than 133,000 cancer cases per year worldwide. The association to Epstein-Barr virus (EBV) infection in the tumor is unanimous (~100%) in NPC-endemic areas, and high (90%) in non-endemic areas such as the U.S. This proposal seeks to define the test performance of a prototypic serology assay and to develop a refined high-throughput EBNA1 IgA assay for NPC risk prediction.